HUMAN ATRIAL NATRIURETIC FACTOR AND AUTONOMIC CONTROL OF CIRCULATION

Acute effects of human atrial natriuretic factor on neurocirculatory control mechanisms and on peripheral vascular homeostatic mechanisms in normal man.